MYOBLAST TRANSFER STUDIES IN DUCHENNE MUSCULAR DYSTROPHY

This study examines the safety and efficacy of myoblast transfer and tests the hypotheses that, (1) myoblast transfer results in expression of dystrophin and functional improvement based on quantitative muscle testing; and 2) immunosuppression is not necessary for successful myoblast transfer.